EFFECTS OF ANTIPLATELET THERAPY ON INJURED VEIN GRAFTS

The purpose of this investigation is to determine the relationship between the morphological integrity of vein grafts at the time of implantation, the subsequent fate of the grafts, and the effects of antiplatelet therapy on that fate. We will compare an IDEAL technique of graft preparaton which preserves endothelial integrity with an INJURY technique to determine the relationship between the morphology of the intima and the media at the time of implantaion and subsequent pathological changes occurring within the graft. We will study the effects of antiplatelet agents on the vein graft wall with respect to the healing of a damaged endothelium. We will determine the involved mechanisms and efficacy of these agents in preventing smooth muscle cell stimulation and/or proliferation, deposition of ground substance, and the interaction of blood-borne cells and platelets with the vein graft wall. Paired reversed cephalic vein bypass grafts in the canine femoral artery will be used. Specimens of vein grafts will be taken at the time of implantation. Grafts will be harvested at varying intervals postimplantation up to 18 months. Light, scanning, and transmission electron microscopy will be used. Areas of platelet adhesion, re-endothelialization, and fibrin deposition as well as intimal and anastomotic hyperplasia will be integrated from a projected microscopic image using a digitized pad. The extent of smooth muscle cell stimulation, proliferation and deposition of intracellular matrix will be determined as related to integrity of the overlying endothelium and antiplatelet therapy. This study will provide important information with regard to the role of endothelial and medial damage in acute and late graft failure. It will define the precise mechanism of vein graft failure and will determine if and how antiplatelet therapy alters that mechanism. It will be relevant to the clinical preparation of vein grafts, the appropriate time course of antiplatelet or other therapy, follow-up arteriography and angiodilatation. This information is very likely to lead to improved results in peripheral arterial and coronary artery reconstruction with reversed vein grafts.